Studying stem cell-based therapies by applying advanced in vivo physiological and imaging methods to transplanted human neural populations in mice

Project Summary/Abstract
Stem cell transplantation therapies are emerging as some of the most promising methods for treating an array
of neurological and neurodegenerative disorders where the primary cause of pathology is cell death. Among
the most exciting of these approaches is the transplantation of human Neural Precursor Cells (hNPCs) that are
derived from human induced Pluripotent Stem Cells (hiPSCs) to replace neuronal loss. For targeted stem cell
therapies to be successful, programmed hNPCs must undergo a complex and dynamic set of processes in vivo
after transplantation, including proliferation, migration, and integration into the existing circuit. Although it is
accepted that all of these processes are critical to the success of hNPC transplantation therapies very little is
known about their dynamics, either in patients or in animal models. The ability to track the changes that hNPCs
undergo once in the neocortex, in vivo over the lifetime of the animal, will provide key insights into the
mechanisms governing transplant integration, as well as the functional impact that transplants have on existing
circuits.
The goal of this proposal is thus to develop cutting edge methods for in vivo imaging and neurophysiology to
study the structural dynamics and functional impact of hNPC transplantation in adult cortical circuits in the
mouse. We are ideally suited to accomplish this goal as we have shown that hNPCs derived from hiPSCs
transplanted into the juvenile mouse integrate into mouse cortical and hippocampal circuits. Furthermore, we
have pioneered multiphoton in vivo imaging and neurophysiology methods in the mouse that will support the
innovations proposed for tracking the structural and functional dynamics of transplanted hNPCs. Using this
expertise, we will accomplish the goal of this project via the following 3 aims.
In aim 1, we will determine the structural maturation of human NPCs transplanted into the adult mouse using
lifetime in vivo 2-photon imaging. In aim 2, we will determine the molecular and cellular identity and
characterize the intrinsic biophysical properties of NPCs engrafted into the adult mouse. In aim 3, we will
characterize the functional properties of neurons differentiated from transplanted hNPCs in the visual cortex of
awake behaving mice.

Public health relevance
Project Narrative This proposal will develop new methods for studying the integration and function of hNPCs transplanted into the mouse brain, thereby providing critical mechanistic insights that will advance the field of stem cell transplantation as a therapy. Mice are one of the major mammalian model organisms for research on stem cell transplant therapy and many organizational principles of cell types and circuits are conserved across evolution, making them critical to understanding neurodegenerative and neurological disorders like Alzheimer’s Disease, Parkinson’s and stroke. This proposal will establish new experimental paradigms to investigate the cell and systems biology of stem-cell transplantation therapies and their functions, thus providing critical clues into why some stem cell strategies are successful and others are not.